Finding a pathway to HIV cure among adolescents on long-standing ART in Botswana through reservoir analysis, analytic treatment interruption, and biomarker assessment

Abstract
Adolescents living with HIV-1, many of whom began antiretroviral treatment (ART) in early life,
are an ideal group to benefit from novel HIV-1 treatment approaches and curative strategies.
However, a better understanding of HIV-1 persistence into adolescence following continuous ART
in childhood is critical for the development of effective cure strategies. In this K43 application, I
propose to develop and get trained on laboratory techniques and next generation sequencing
techniques to advance an HIV-1 cure research program in Botswana with specific aims to 1) first
identify adolescents with low reservoir without detectable intact virus (Type I controllers) or those
with a blocked and locked reservoir profile (with detectable intact proviruses with non-genic
chromosomal integration (Type II controllers) from a cohort of adolescents who were perinatally
infected with HIV-1 and having been on ART since the first 2 years of life. 2) Evaluate how the
reservoir changes over time in the same adolescent cohort living with HIV-1C while for those with
‘blocked and locked’ reservoir profile, if they agree, I will enroll them into the Tatelo Plus ATI study
(U01AI179561) to test the hypothesis that those with a ‘blocked and locked’ reservoir profile (Type
II) may be post-treatment controllers and evaluate how their reservoir evolves pre and post ATI;
and 3) identify biomarkers associated with the potential for Type I or Type II control. I am originally
from Botswana and I hold a PhD in Immunology and Virology, Master’s degree in Immunology,
and a Bachelor’s degree in Medical Microbiology. I completed my postdoctoral fellowship at
Harvard T H Chan School of Public Health and the Ragon Institute in 2022 and have now returned
to my home country Botswana, where I am in the process of setting up an adolescent HIV-1 cure
research program and planning to become an independent investigator at the Botswana Harvard
Health Partnership. This proposal will most importantly support my mentored career development
and assist me advance the HIV cure research in Botswana.

Public health relevance
Project Narrative In Botswana, many adolescents and young adults have received continuous ART for nearly two decades and are ideal candidates for research into functional HIV cure. In this K43 application, I propose to assess a cohort of early-treated adolescents by carrying out an in-depth characterization of their proviral reservoir, assessing mechanisms of possible viral control, evaluate how the reservoir evolves in this cohort of adolescents while I leverage an existing U01- supported analytic treatment interruption protocol (U01AI179561) for selected participants (enrolling those with a blocked and locked reservoir profile), and finally identify potential markers of functional cure. This award will help me develop research skills and advanced laboratory techniques for HIV cure research in Botswana and prepare me to conduct independent research.